Neurocognitive and neuroimaging markers of emerging cerebral adrenoleukodystrophy

Project Summary/Abstract
Adrenoleukodystrophy (ALD) is a progressive X-linked neurological disorder with unpredictable variation in
expression. During childhood, about 1 in 3 boys develop rapidly progressing cerebral ALD with brain
inflammation and myelin destruction. Although existing treatments stop progression of cerebral ALD when
detected at an early stage, no current assessments can identify which boys will develop cerebral ALD or when
it will begin. Newborn screening programs that identify ALD at birth offer an opportunity to provide earlier
treatment that avoids irreversible neurocognitive decline while new treatments may present safer alternatives
to standard stem cell therapy. This K23 Career Development Award aims to provide the PI with the necessary
training to become an independent investigator proficient in cross-modal methodologies to measure subtle
brain changes in children with ALD and apply those methods in clinical research protocols. With mentorship
from a team of experts at the University of Minnesota, the applicant proposes the following training objectives:
(1) to obtain knowledge and experience in acquisition and analysis of neuroimaging data; (2) to learn statistical
and computational methods for validation of novel neurocognitive tests; and (3) to acquire the expertise to
design and execute clinical trials. The overall research objectives are designed to identify early neurocognitive
and neuroimaging markers of cerebral demyelination and enhance the capacity of clinical trials of newer
therapies to define robust endpoints for boys who receive early treatment. The central hypothesis is that
deterioration in white matter fiber integrity and associated loss of interhemispheric function involving the corpus
callosum mark the onset of cerebral ALD, and begin prior to the appearance of a lesion on MRI. To test this
hypothesis, the PI will test several methods designed to measure changes associated with demyelination. The
specific aims will use longitudinal neurocognitive testing (Aim 1) and longitudinal diffusion MRI studies (Aim 2)
to identify functional and microstructural markers of cerebral ALD in boys with early stage disease, and test for
presence of these markers during the critical pre-emergent stage in at-risk boys. The neurocognitive findings
will also be compared to MRI metrics of disease progression. The successful completion of these Aims will
identify reliable indicators of disease onset and early progression. The proposed research is significant
because detection and quantification of subtle progressive brain changes in boys with ALD will allow earlier
and more effective intervention to reduce the neurocognitive morbidity. The training objectives will support the
applicant's career goals to lead a long-term program of research to identify sensitive markers of brain
dysfunction in neurodevelopmental and neurodegenerative diseases, with the goal of informing timing and
efficacy of interventions to achieve better patient outcomes.

Public health relevance
Project Narrative As newborn screening is now available for X-linked adrenoleukodystrophy, there is a need to establish meaningful disease markers to detect the onset of the severe demyelinating cerebral form of this disease at the earliest possible stage, and to quantify early disease progression to evaluate the relative efficacy of treatments. The proposed research study is relevant to public health because it may facilitate detection of neurocognitive and microstructural brain changes in individuals with emerging cerebral disease before MRI lesions appear and substantial neural injury has occurred, thereby improving outcomes for individuals with this difficult-to-treat neurological disorder.